Applying a Targeted Machine Learning and Causal Inference Approach to Analyzing Long-Term Sequelae of COVID-19 Infection Through the National COVID Cohort Collaborative.

Candidate: I am an epidemiologist in the Division of Biostatistics at the University of California, Berkeley School of Public Health, and I completed my Ph.D. in Epidemiology in August 2022 at UC Berkeley. Since my graduation, I have worked with the Center for Targeted Machine Learning and Causal Inference to apply cutting-edge biostatistical and causal inference methods to pressing research questions using electronic health record (EHR) data from the National Clinical Cohort Collaborative (N3C). I aim to become a leader in applying innovative biostatistical, causal inference, and machine learning methods to address impactful research questions in infectious disease epidemiology using electronic health record data.
Environment: To achieve my career goals, my training and mentorship plan will focus on recent advances in biostatistics, causal inference, and data science methods, as well as infectious disease epidemiology. I have assembled an interdisciplinary team of expert biostatisticians, epidemiologists, and clinicians who will support my training. Alan Hubbard (primary mentor) and Mark van der Laan (co-mentor) will provide expert guidance and mentorship on biostatistics, data science, and causal inference. Rena Patel (co-mentor) and Jack Colford (scientific advisor) will provide mentorship and guidance in infectious disease epidemiology.
Research: Researchers and clinicians have made significant progress in understanding, preventing, and treating the acute stages of viral infections. However, there is considerable uncertainty regarding interventions to prevent or treat the long-term sequelae of viral infections, which are a growing source of morbidity and mortality. In this project, I will evaluate the effectiveness of several promising medications and interventions in preventing long-term sequelae and mortality following viral infection. In Aim 1, I will evaluate the impact of diabetes medications (metformin and GLP-1 receptor agonists) on mortality and long-term symptomatology among patients with comorbid diabetes and viral infection. In Aim 2, I will assess the impact of interleukin-6 modulating drugs (tocilizumab and sarilumab) on mortality and long-term sequelae in a cohort of patients with comorbid moderate rheumatoid arthritis and viral infection. In Aim 3, I will develop, evaluate, and disseminate advanced methods for applying causal inference, machine learning, and biostatistics to EHR data. In Aim 4, I will evaluate the relationship between vaccination timing, relative to acute infection, and long-term sequelae of infection, in order to determine an optimized vaccination schedule. I will apply targeted machine learning methods to achieve these aims, which will prepare me for an R01-level application to utilize these methods in research questions related to infectious disease epidemiology and analysis of EHR data.

Public health relevance
This project aims to inform how we can repurpose medications and other interventions to reduce long-term sequelae and mortality following viral infections by analyzing electronic health record data. This work will inform infectious disease treatment strategies and advance causal inference methods for electronic health record data, strengthening our understanding of and preparedness for viral threats. References 1 National Institutes of Health. About the National Clinical Cohort Collaborative. National Center for Advancing Translational Sciences 2023. URL: https://ncats.nih.gov/n3c/about. 2 Halabitska I, Petakh P, Lushchak O, Kamyshna I, Oksenych V, Kamyshnyi O. Metformin in Antiviral Therapy: Evidence and Perspectives. Viruses 2024;16:. https://doi.org/10.3390/v16121938. 3 Li Y-S, Ren H-C, Cao J-H. Roles of Interleukin-6-mediated immunometabolic reprogramming in COVID-19 and other viral infection-associated diseases. Int Immunopharmacol 2022;110:109005. https://doi.org/10.1016/j.intimp.2022.109005. 4 Sato T, Shimizu T, Fujita H, Imai Y, Drucker DJ, Seino Y, et al. GLP-1 Receptor Signaling Differentially Modifies the Outcomes of Sterile vs Viral Pulmonary Inflammation in Male Mice. Endocrinology 2020;161:. https://doi.org/10.1210/endocr/bqaa201. 5 Tanaka T, Narazaki M, Kishimoto T. IL-6 in inflammation, immunity, and disease. Cold Spring Harb Perspect Biol 2014;6:a016295. https://doi.org/10.1101/cshperspect.a016295. 6 van der Laan MJ, Rose S. Targeted learning: causal inference for observational and experimental data. New York: Springer; 2011. 7 Van der Laan MJ, Rose S. Targeted learning in data science: causal inference for complex longitudinal studies. New York, NY: Springer Berlin Heidelberg; 2017. 8 van der Laan M, Coyle J, Hejazi N, Malenica I, Phillips R, Hubbard A. Targeted Learning in R: Causal Data Science with the tlverse Software Ecosystem. 2023. 9 Bonanni P, Heo JY, Honda H, Lee P-I, Mouliom A, Leong HN, et al. Optimal Timing of Vaccination: A Narrative Review of Integrating Strategies for COVID-19, Influenza, and Respiratory Syncytial Virus. Infect Dis Ther 2025;14:911–32. https://doi.org/10.1007/s40121-025-01135-0.